Project 1: Molecular Pathogenesis and Therapy of Myelofibrosis

ABSTRACT
Patients with the myeloproliferative neoplasms (MPNs) Polycythemia vera (PV), essential thrombocythemia
(ET), and primary myelofibrosis (PMF) suffer progressive cytopenias, bone marrow fibrosis and/or
transformation to acute leukemia. The identification of somatic activating mutations in the JAK-STAT pathway
in the majority of MPN patients led to the clinical development of JAK kinase inhibitors. Although they provide
important clinical benefit, current JAK inhibitors do not show disease-modifying activity in most patients. In
addition, recent studies have shown that mutations in the chromatin modifier ASXL1 are associated with
adverse clinical outcome in PMF. These data underscore the need novel therapeutic approaches for MF
patients based on mechanistic insight into disease pathogenesis. We propose to investigate the mechanisms
by which JAK2 and ASXL1 mutations cooperate to induce myeloid transformation, and to investigate novel
therapeutic approaches in MF. This will include studies which evaluate the impact of concurrent JAK-STAT
pathway and ASXL1 mutations on MPN pathogenesis, progression and therapeutic resistance to targeted
therapies. We will also investigate the role of novel therapeutic approaches, specifically type II JAK2 inhibitors
and combined signaling/epigenetic therapies targeting JAK2 and EZH2 in MF murine models and primary
patient samples. The studies in this project will leverage novel, genetically accurate murine models coupled
with detailed studies of primary samples from the MPN-RC sample bank. Most importantly, the studies in this
project are aimed to credential novel therapeutic approaches which can then be transitioned to the clinic for
near-term mechanism based clinical trials in this research consortium.

Public health relevance
PROJECT NARRATIVE There is a need for new treatments for myelofibrosis (MF) patients based on laboratory insight into disease pathogenesis. We will use studies of murine models of MF and primary patient samples to understand how different genetic mutations contribute to MF development and to test novel treatment approaches. Most importantly, the studies in this project are aimed to validate novel therapies that can then be rapidly tested in clinical trials in this research consortium.